Exercise Effects on the Neurobiology Underlying Stress-Related Eating Behaviors in Veterans

The prevalence of overweight or obesity among Veterans was recently estimated to be 78%. Given the
associations between obesity and comorbid medical conditions, increased disability levels, and reduced quality
of life, this represents a significant health concern for Veterans. A contributing factor is stress, which is
associated with increased rates of obesity, diabetes, and cardiovascular disease. One mechanism by which
this occurs is via stress effects on eating behaviors. Stress is associated with increased food cravings,
overeating, and poor nutritional choices. Stress is known to alter brain function in multiple areas and networks
involved in reward processing and inhibitory function, which are highly relevant to eating behaviors. As such,
identifying intervention approaches that can support stress resilience in brain regions and circuits involved in
eating behaviors may be particularly helpful in reducing unhealthy eating behaviors in response to stress. An
attractive candidate for this purpose is exercise. While exercise has been associated with beneficial effects on
stress responsivity, the effects of endurance exercise training on stress-related eating have not been
investigated. Furthermore, exercise training effects on the neurobiology underling stress-related eating
behaviors are unknown. As such, the proposed study will examine how exercise training impacts the
neurobiological mechanisms underlying stress-related eating.
The proposed project aims to determine the effects of 12 weeks of endurance exercise training (EX),
compared to a wait-list control (WL), on eating-related neurobiology during “stressed” (following a psychosocial
stress task) compared to “not stressed” conditions in Veterans with overweight/obesity who report chronic
stress and stress-related eating behaviors. Brain response to visual food cues will be assessed via functional
magnetic resonance imaging (fMRI) at baseline and post-intervention in each stress condition. We hypothesize
that EX, compared to WL, will reduce the impact of stress on the neuronal response to food cues in brain
regions associated with reward processing and inhibitory function. Additionally, we hypothesize that EX-
associated neuronal changes will be associated with corresponding reductions in stress responsivity during the
stress task (cortisol, heart rate, subjective stress), alterations in appetite-related peptides, and diminished
appetite, food ratings, and ad libitum food intake following the stress task. Given that women represent the
fastest growing Veteran population, and that previous studies have observed sex-based differences in eating
behaviors, brain responsivity to food cues, and overall stress responsivity, sex differences in these effects will
also be examined.
The proposed study will improve both our understanding of the neurobiological mechanisms underlying stress-
related eating, as well as the impacts of exercise training on this neurobiology. A better understanding of these
effects will support development and optimization of obesity mitigation and treatment approaches for Veterans.
Additionally, understanding sex differences in the neurobiology underlying stress-related eating, and how this
is affected by exercise training, will provide a mechanistic background from which to develop sex-specific
treatment approaches. Given the contribution of stress-related eating to weight gain and obesity, this proposal
is highly relevant to Veterans’ health and addresses the CSRD priority research areas of health-risk behaviors
and women Veterans’ health.

Public health relevance
Overweight and obesity represent a significant health problem for Veterans. A contributing factor is stress, which is associated with increased food cravings, overeating, poor nutritional choices, and obesity itself. Stress is known to alter function in brain areas and networks involved in reward processing and inhibitory control, which are highly relevant to eating behaviors. As such, identifying intervention approaches that can support stress resilience in eating-related brain regions and circuits may be particularly helpful in reducing unhealthy eating behaviors in response to stress. As exercise has been associated with reduced stress responsivity, this study will examine how exercise training impacts neurobiological mechanisms underlying stress-related eating. Given that women are the fastest growing Veteran population, and that sex differences are observed in obesity prevalence, eating behaviors, and stress responsivity, the study will also investigate how sex impacts these effects.